The role of spatiotemporal dopamine coordination in disrupted state representation processes in mice

PROJECT 2 - PROJECT SUMMARY
The purpose of PROJECT 2 is to use mice as an experimental model to help clarify the relationship between
cortical and subcortical dopamine (DA) activity disruptions and state representation changes in psychosis,
specifically by focusing on how striatal hyperdopaminergia relates to cortical synchrony and NMDAR
dysfunction. Deficits in representing and learning about states of the world underlie maladaptive cognitive
control and reward learning in psychosis, and frontostriatal-DA interactions are critical to adaptively regulating
these processes in service of behavioral flexibility. Despite decades of research, our understanding of the
precise computational and circuit-level mechanisms that contribute to the manifestations of
psychosis—particularly the role of DA activity across spatial and temporal scales —remains incomplete.
Specifically, what spatiotemporal circuit interactions link DA dynamics in the caudate striatum to state
estimation, state representational stability (maintenance), and learning of reward-predictive states?
Using our novel optical preparation for manipulating and imaging large-scale DA dynamics across the entire
rodent dorsal striatum, we will specifically focus on how striatal hyperdopaminergia and NMDAR dysregulation
affect parameters of tightly coordinated spatiotemporal DA patterns within and across the dorsal striatum,
ventral striatum, and medial prefrontal cortex (mPFC). Our goal is to combine circuit, behavioral, and
computational approaches to link state representation disruptions seen in psychosis to computational
operations regulated by dopaminergic modulation of frontostriatal circuits.
Aim 1: Assess how DS spatiotemporal DA coordination is affected by various models of
psychopathology. We will image DA in mPFC, dorsal, and ventral striatum with i) pharmacological modeling
of hyperdopaminergia using modafinil (in synergy with PROJECT 5) and ii) pharmacological blockade and
genetic ablation of cortical NMDA receptors (in synergy with PROJECTS 1, 3, and 5). We will also assess
whether the DA effects of psychotomimetic conditions are restored by risperidone, a D2R antagonist used in
the treatment of psychosis. Aim 2: Investigate the coordination of cortical and striatal DA signals during
a probabilistic behavioral task that parametrizes state learning. Using simultaneous, multi-region DA
measurement across mPFC, caudate, putamen, and accumbens in the Translational Bandit Task (TBT), we will
extend our previous analysis of decision signals relayed by regional DA signals in motivation and action value
learning. Task manipulations and analyses will parallel other Projects to maximize the translation interpretability
of our findings across species.